Prevalence and Effects of “Natural” Descriptors on Cigar Packaging

PROJECT SUMMARY
The 2016 Deeming Rule extended FDA’s regulatory authority to cigars, including cigar labeling and
marketing. Cigars pose similar health risks as cigarettes but are far cheaper and disproportionately used by
young people and minorities, particularly Black and African Americans. Prior research has shown cigar
packaging features such as color and flavor descriptors can influence favorable cigar perceptions and use
intentions, but little is known about the effects of “natural” descriptors in cigar marketing, which appear to be
growing in use and may mislead consumers into thinking these products pose lower risks. Evidence from
cigarette literature has documented misleading effects of “natural” descriptors, leading the FDA in 2015 to
order makers of Natural American Spirit cigarettes and other cigarette brands to cease use of the “natural”
descriptor in their advertising. While FDA can extend similar restrictions to cigars, cigar-specific data is needed
to examine whether similar misleading effects of “natural” descriptors occur in the cigar marketing domain to
inform any potential regulatory actions. This project will use complementary methods to extend the evidence
base regarding use of “natural” descriptors and imagery to cigar packaging, including its prevalence, growth
and impact on young adults’ attention, cigar perceptions (including risk perceptions), appeal, and use
intentions. In Aim 1 we will analyze Nielsen cigar sales data and purchased cigar packs over the project period
to examine use of various “natural” themed descriptors (both explicit and alternative) and imagery (e.g.,
tobacco leaves) on cigar packaging over time. Under Aim 2 we will test the effects of “natural” descriptor types
and imagery on cigar packaging (as well as interactions with cigar product images) on young adults’ cigar
product perceptions and use intentions using an online experiment with young adults (ages 18-34) who
currently use cigars and non-users susceptible to cigar use. We will also conduct a second exploratory online
experiment examining the interaction between “natural” descriptors/imagery and potential health
communication messages on cigar packs (i.e., text and pictorial warning labels, and “natural does not mean
safer” disclaimers). We will complement our Aim 2 study results by examining likely real-world attention to
“natural” descriptors and imagery through an in-person eye-tracking study with 160 young adults (Aim 3). This
study will inform FDA research priorities on Marketing Influences, Communications, and Behavior, and relevant
cigar regulatory actions.

Public health relevance
PROJECT NARRATIVE Cigar use is disproportionately high among young people and minorities. Descriptors and imagery on cigar packaging describing cigar products as “natural” are growing in use, and may influence cigar perceptions (including misperceptions that they are “less harmful”) and use intentions. The proposed research aims to provide cigar-specific evidence on the prevalence and impact of “natural” descriptors and imagery on young adults’ attention, cigar perceptions, and use intentions, with the aim of informing potential regulatory actions and counter-strategies.